Importance of muscle-subtendon units in Achilles tendinopathy

Project Summary
Achilles tendinopathy is a prevalent and painful condition that hinders physical activity, with a significant
incidence in the general population. Current treatments primarily involve calf-strengthening exercises, but
success rates vary, leading to persistent symptoms in many patients. The Achilles tendon is composed of three
subtendons twisted into a bundle and each linked to one of three individual muscles in the triceps surae, with
each subtendon-muscle unit serving a distinct function. This intricate anatomy – which has yet to be considered
in the development of treatment options for tendinopathy – may explain the varied responses to treatment. This
study aims to explore the complex structure of the Achilles tendon to understand why some patients respond to
generalized exercise treatments while others do not. This proposal integrates advanced in vivo techniques,
including novel biomechanical sensors and cutting-edge medical imaging, with state-of-the-art modeling
approaches to assess the structure and function of Achilles subtendons in patients with Achilles tendinopathy.
The long-term goal of this work is to develop diagnostic and therapeutic strategies tailored to the individual
structures of muscle-subtendon units. As a critical first step, this proposal will advance our understanding of the
relationship between muscle-subtendon unit anatomy and Achilles tendinopathy and employs a three-stage
approach. In Specific Aim 1, we will complete a longitudinal assessment of specific muscle responses to
standard-of-care exercise treatments. To do this, we will track changes in muscle-subtendon units in 50 patients
with tendinopathy over 12 weeks of exercise treatment. Using MRI, ultrasound, elastography, and biomechanical
assessments, the study will analyze how different muscle-subtendon units respond to standard treatment. In
Specific Aim 2, we will perform a high-field MRI study to assess the subtendon-specific damage incurred in
Achilles tendinopathy. Using a research-grade MRI scanner and our newly-developed techniques, we will image
tendons in patients with Achilles tendinopathy in high-resolution, allowing us to create previously inaccessible
3D subtendon reconstructions and region-specific effects of tendinopathy, providing detailed anatomical maps
of tendon damage. Finally, in Specific Aim 3, we will develop and interrogate subject-specific computational
models to simulate therapeutic loading via targeted muscle activation intervention. These models will compare
the mechanical effects of generalized versus subtendon-specific treatment, predicting mechanical effects and
potential failure modes based on individualized anatomy. Our interdisciplinary team aims to create a new
paradigm for understanding the muscle-subtendon unit specific responses to Achilles tendinopathy treatment,
exploiting the unique structure of each patient's Achilles tendon. This research will enhance understanding of
anatomic variability in Achilles tendinopathy and lead to more effective, personalized clinical interventions.

Public health relevance
Project Narrative Achilles tendinopathy is a painful and debilitating condition, and unfortunately the gold-standard treatment – exercise-based therapy – is sub-optimal in nearly half of all patients and has high reoccurrence rates. The complex anatomy of the Achilles tendon, which connects the heel to three separate muscles in an anatomical arrangement that varies across people, may lead to this inconsistency in success rates with the current one- size-fits-all treatment. This proposal aims to improve our understanding of the relationship between the complex anatomy of the Achilles tendon and the injury caused by Achilles tendinopathy so that we can better target affected regions in future clinical treatments.